Mechanisms of vaccine interference by S. aureus-induced imprints

Abstract / Summary
Staphylococcus aureus (SA) is a leading cause of infection worldwide and a major driver of antibiotic
resistance. Although there have been close to thirty vaccine trials targeting the pathogen, all successful
pre-clinical vaccines taken to human trials have failed for unclear reasons. Recently, we provided
evidence that SA vaccine failures occurred because of routine and frequent human exposure to SA
compared to laboratory mice. We showed that prior exposure of mice to SA leads to the development
of anti-SA antibodies with increased Fc sialylation, incapable of supporting opsonophagocytic killing of
the pathogen. Staphylococcal vaccination of these pathogen-exposed mice recalls the non-protective
antibody response and leads to vaccine failure. Using this model, we have successfully explained the
failure of all clinical SA vaccines we have tested to date. To understand the mechanistic basis for the
vaccine failures, we now show that SA induces abundant IL10 that enhances Fc sialylation of non-
protective antibodies. IL10 also blocks anti-SA cellular immunity by antagonizing TH17 generation.
Taken together, we hypothesize that non-protective immune imprints develop as a result of IL10
induced by the pathogen, and IL10 underlies the development of non-protective responses by
subsequently administered T and B vaccines targeting SA. To test our hypothesis, 1) we propose to
investigate the molecular link between IL10 and Fc glycosylation, and the mechanism whereby Fc
glycosylation leads to aborted opsonic killing of SA. 2) We will seek to identify the bacterial source of
IL10 induction and address the mechanism of IL10+T cell expansion and IL10-mediated suppression of
TH17 development. 3) Finally, we will address the practical strategic implications of these findings on
vaccine development. Overall, our proposal aims to understand the interaction between SA, the host,
and the vaccine to provide new insights on anti-SA vaccine approaches. Our findings has the potential
to shed light on why vaccines targeting other pathogens also failed.

Public health relevance
Project Narrative We have shown that prior exposure to S. aureus leads to blunted humoral and cellular staphylococcal vaccine responses. Here we test the hypothesis that IL10 induced by prior S. aureus exposure underlies the non-protective T and B cell responses to S. aureus vaccines.